Fetal neuronal extracellular vesicle biomarkers of in-utero effects of maternal cannabinoid use and human fetal brain development and neurobehavioral outcomes

This proposal aims to determine whether biomarkers in fetal central nervous system-derived
extracellular vesicles (CNSEVs) are useful predictors of derangements in fetal
neurodevelopment in women using cannabinoids during pregnancy compared to controls. NOT-
DA-20-039: Notice of Special Interest (NOSI): Effects of Cannabis Use and Cannabinoids
on the Developing Brain specifically requests translational projects that will enhance our
understanding of the how cannabinoids affect both cellular and molecular events specific to
neural plasticity and the impact of these alterations on subsequent cognition and behavior.
Purification of CNSEVs from maternal blood allows noninvasive evaluation of fetal CNS
cannabinoid targets without significant contamination from each other or non-CNS sources. The
surface protein used to isolate fetal CNSEVs, Contactin-2/Tag-1 specifically targets neurons
undergoing synaptic plasticity and has been validated with respects to its ability to specifically
target fetal neurons with little contamination from maternal neurons or other organs. To achieve
these goals pragmatically we have partnered with an ongoing NIH funded clinical cohort of 450
subjects (5RO1DA054722) that includes clinically relevant neurobehavioral outcomes including
fetal fMRI between 35 and 37 weeks gestational age, Finnegan score at birth and measures of
executive function at 12 and 24 months (Lab-TAB and Minnesota EF Task). The proposed
project with focus on the identification of novel protein and miRNA biomarkers of these
outcomes and sex differences in these biomarkers. The completion of this project with result in
improved counseling of pregnant women regarding the safety of cannabis use in pregnancy,
effective clinical/research tools for the ongoing non-invasive monitoring of the fetal brain over
the course of pregnancy, and identify changes at the molecular/cellular level associated with
cannabis use that may reveal novel targets for neuroprotection.

Public health relevance
This study will develop new non-invasive tests to track fetal brain development over the course of pregnancy and use these tests to identify the effects of prenatal cannabis exposure. Given the increasing use of cannabis products for both nausea and vomiting of pregnancy in the first trimester and throughout pregnancy for recreational use, the almost complete lack of evidenced- based counseling on the consequences remains a critical public health knowledge gap.